Unified Shim-RF Coil Technology for Improved Whole-Brain Spectroscopic MRI for Neurological Disorders

Project Summary/Abstract
Neurologic diseases affect as many as one billion people worldwide and are a major cause of disability and
human suffering. Current standard of care imaging (contrast-enhanced MRI) is extremely limited to detect many
neurological and neurodegenerative diseases. MR spectroscopic imaging (MRSI) has a great potential to
supplement routine clinical MRI for clinical conditions including brain neoplasms, neonatal and pediatric
disorders (hypoxia-ischemia, inherited metabolic diseases, and traumatic brain injury), demyelinating diseases,
and infectious brain lesions. Gadolinium contrast agents have incomplete clearance, and repeated use of
contrast-enhanced imaging has recently received an FDA warning due to brain accumulation. MRSI does not
use contrast material and has no/minimal risk for patients. 3D encoded MRSI methods provide high sensitivity
per unit time and unit volume. Presurgical and radiation treatment planning will greatly benefit from full 3D
information, ideally with isotropic resolution. Echo-planar spectroscopic imaging (EPSI) based 3D whole-brain
MRSI have been on most scanner platforms, and are probably the most commonly used fast MRSI techniques
to date. The primary limitation of 3D MRSI has been magnetic B0 field inhomogeneity, which broadens lineshapes
and diminishes spectral quality in about 40% of the brain (e.g., mesial temporal lobe, inferior frontal cortex,
medial frontal gyrus, brainstem, and cerebellum). This limits the ability to evaluate critical brain regions such as
mesial temporal lobe (MTL) and orbitofrontal cortex (OFC), which have pivotal roles across neurologic disorders.
Recently, we introduced a radically novel concept called Unified Coil (UNIC), which includes innovative
decoupling methods to bring the distance between separate shim and RF loops to zero millimeters. Both RF and
shim coils are at a close proximity to the target organ for maximized RF SNR and shimming. Physical law implies
that the only effective way to shim local inhomogeneous field (as in MTL/OFC) is by placing size-matched shim
coils which generate opposite high-order field to counteract the inhomogeneous field. Our hypothesis is that
UNIC will dramatically increase brain volume coverage and allow true metabolic evaluation of the entire brain
using 3D MRSI. This will enable broader applications in patient management with various neurological disorders.
The proposed study will prototype the first UNIC head coil (Aim 1), optimize the technique in shimming
performance and hardware complexity (Aim 2), and assess the technique quantitatively in improving brain
coverage of 3D MRSI (Aim 3). Successful completion of this study will largely resolve the longstanding B0
inhomogeneity issue in whole brain. Such coils can be widely used to benefit the entire MRSI community by
advancing B0 shimming technology. It will help catalyze the widespread clinical acceptance of MRSI.

Public health relevance
Project Narrative Current standard of care imaging (contrast-enhanced MRI) is limited to detect many neurological and neurodegenerative diseases and spectroscopic MRI has a great potential to supplement routine clinical MRI for clinical conditions including brain neoplasms, neonatal and pediatric disorders (hypoxia-ischemia, inherited metabolic diseases, and traumatic brain injury), demyelinating diseases, and infectious brain lesions. This project will improve whole brain coverage and reliability of Spectroscopic MRI, which will be quantitatively assessed in collaboration sites. Successful completion of this study will produce new generation tools needed for broader applications of spectroscopic MRI in patient management with various neurological disorders.